SYMPATHETIC NEUROVASCULAR FUNCTION IN DIABETES MELLITUS

The overall goal of this study is to develop an innovative approach to characterize and quantitate sympathetic neuropathy and its effects on microvascular tone in subjects with diabetes.